2023 GenomeTrakr Meeting

FOA PAR-23-072
2023 GenomeTrakr Meeting
Summary-Abstract
APHL has the experience and competence to effectively host a high-quality 2023
GenomeTrakr Meeting in College Park, MD, in October of 2023 using the approach
described in the proposal. This meeting will allow participants of the GenomeTrakr (GT)
Network from across the U.S. and worldwide to interact with network leadership to
exchange the latest information on sample collection, whole genome sequencing
protocols, data submission, standardized metadata ontologies, and data analysis
software. Explorations of this nature in the setting of the GT Meeting will enable public
health officials to speed outbreak investigations and reduce foodborne illnesses and
deaths. This purpose aligns with ORA's commitment to building integrated laboratory
capacity and capability and supporting the groundbreaking work achieved through the
GT network.

Public health relevance
FOA PAR-23-072 2023 GenomeTrakr Meeting Project Narrative The 2023 GenomeTrakr Meeting will allow participants of the GenomeTrakr (GT) Network from across the U.S. and worldwide to interact with network leadership to exchange the latest information on sample collection, whole genome sequencing protocols, data submission, standardized metadata ontologies, and data analysis software. The GT Meeting will be the opportunity to further develop and enhance the network as an early warning mechanism for foodborne outbreaks by facilitating information exchange with and between member laboratories, domestic and globally, on foodborne illnesses and pathogens isolated from food samples. The purpose of this Meeting aligns with ORA's commitment to building integrated laboratory capacity and capability and supporting the groundbreaking work achieved through the GT network.